MECHANISMS OF NEUROPROTECTION AGAINST CARDIAC ARREST

Project Summary
Cardiac arrest remains one of the leading causes of death and disability in the U.S.A. This proposal is a
competitive renewal application. In the previous funding cycle, we defined the pathophysiological mechanisms
impairing functional recovery following asphyxia cardiac arrest (ACA). Because CA promotes significant
cognitive deficits, our central emphasis in the previous cycle was to understand the mechanisms behind ACA
induced synaptic deficits and to establish novel, mitigating therapies against these deficits. Furthermore, new
evidence in heart failure (HF) patients indicate that brain alterations in these patients are similar to regions
affected by Alzheimer's disease (AD), suggesting that HF may be a major risk factor for AD. We discovered, in
our previous studies, that physical exercise (PE) following ACA significantly enhances cognitive recovery. To
require ailing, elderly CA patients, however, to adhere to a chronic exercise regimen presents a major obstacle.
Therefore, we focus this competitive renewal on defining the mechanisms by which PE ameliorates cognitive
deficits following ACA, and specifically defining potential post-ACA neurotherapeutics to act synergistically, with
mild, beneficial PE. These goals will be achieved in the following specific aims: 1) To determine the effect of
post-ACA PE on synaptic function, cognitive outcomes, and AD-like pathology of young female and male rats;
2) To identify molecular factors mediating the ameliorating effects of PE on cognitive deficits following ACA; and
3) To determine whether the combination of PE with pharmacological agents mitigates cognitive deficits and
improves functional recovery after ACA in aged animals of both sexes.

Public health relevance
Cerebral ischemia in the form of cardiopulmonary arrest remains one of the leading causes of death and disability in the USA. A major pathological consequence of cardiac arrest is cognitive deficits. This proposal examines the molecular mechanisms by which physical exercise and its potential downstream pathways can ameliorate cognitive deficits following cardiac arrest. The goal is to find novel therapeutic agents that act synergistically with physical exercise that may benefit patients that undergo acute myocardial infarction.